MEDICINE OR SURGERY--TREATMENT ALTERNATIVES FOR ABNORMAL UTERINE

Compare medical and surgical treatment for abnormal uterine bleeding with or without co-existing uterine myomata in premenopausal women. Those who do not respond to medical management will be randomized to enhanced medical management or surgery. Those randomized to surgery will undergo hysterectomy.